Research and Data Analysis Core (RDAC) - WA LHS E-STAR

RDAC - SUMMARY
The Research and Data Analysis Core (RDAC) will support partnerships between E-STAR scholars and
primary care organizations (PCOs) to execute collaborative LHS research projects. We will ensure the success
and utility of LHS projects at 4 Federally Qualified Health Centers (FQHCs)—Community Health Association of
Spokane, Community Health of Central Washington in Eastern Washington, Healthpoint, NeighborCare—and
one integrated health system—Kaiser Permanente Washington (KPWA). We will also serve in an advisory role
for the LHS scholar embedded at Veterans Affairs Puget Sound (VA). This Core will be co-led by Drs. Coley
(Kaiser Permanente Washington Health Research Institute [KPWHRI]) and Ornelas (University of Washington
[UW]) who bring expertise in quantitative and qualitative methods, participatory approaches, patient centered
methods, comparative effectiveness and health equity. The RDAC will conduct a needs assessment with
FQHCs to identify potential LHS research projects, using systematic evidence reviews, meetings, and in-depth
interviews with community members and stakeholders. The assessment will evaluate FQHC readiness and
capacity for research collaboration in priority areas by analyzing health system data availability and quality.
The RDAC will partner with PCOs and LHS scholars to plan and execute collaborative research projects. A
focus throughout study design and implementation will be enhancing PCO capacity and LHS scholar skills. Our
approach is informed by PCORI methodology standards and community-based participatory research (CBPR),
focusing on identifying evidence gaps, researching potential patient-centered solutions, and disseminating
evidence to improve care delivery and health equity. Once projects are complete, the RDAC will facilitate
dissemination and implementation of project findings to the learning community and external audiences. This
will include partnering with PCOs to implement proven interventions to improve primary care. Dissemination
activities targeted to health care organizations will support clinical practice, policy advocacy and long-term
organizational changes. RDAC will also assist with preparing dissemination products (e.g., reports, toolkits,
and published manuscripts) for diverse audiences. Our ultimate goal is to support primary care organizations in
achieving the Quintuple Aim outcomes of health equity, clinician well-being, better health for patients, improved
population health, and lower costs.

Public health relevance
Project Narrative not required for this component.